Administrative Core

Project Summary
The Administrative Core will assist in all the aspects of administration, communication, and overall
conduct of the partnership between the Icahn School of Medicine at Mount Sinai (MSSM) and
Hampton University (HU). It will act to promote the integration between the two Institutions,
organize meetings of the faculty and Advisory Committees, and facilitate participation in the
cancer education training program. The Administrative Core will provide support for personnel
involved in the administration, scientific oversight and coordination, communication, budgetary
oversight, and clerical functions associated with the overall research program proposed in this
partnership grant application.
The Core will facilitate and foster communication, coordination, and collaboration between HU
and MSSM in genetics and genomics training and education, both at the site and long distance.
It will also contribute to engage faculty members in cutting edge genetics and genomics
translational cancer research, with the overarching goal to build the bases for a sustainable
Center for Genetics and Genomics Cancer Research at HU.
The Core will be responsible for the coordination of the Program. Although the investigators have
previously developed long-lasting established collaborative interactions, achieving the integration
needed for a successful and sustained collaboration in genetics and genomics research, with
federally funded grant support will require a higher level of communication and interaction among
the PIs, trainees and staff, as well as the two partners Institutions as a whole.
The approach to coordination will include electronic communication (video conferencing and a
web-based content management system for document sharing, messaging, and calendaring) as
well as in person meetings. These will include meetings of the project investigators and their team,
meetings of the Leadership and Internal Advisory Committees, as well as distance learning for
the education segment of the program.